Decoding Astrocyte Signaling in Neural Circuitry with Novel Computational Modeling and Analytical Tools

Astrocyte is the most abundant glia cell and significantly outnumbers neuron in the human brain. Long thought
to be primarily passive cell, astrocyte has been increasingly recognized as essential player with active regulatory
role in neural circuitry and behaviors. Since a single astrocyte interacts with thousands of synapses, other glial
cells and blood vessels, it is well positioned to link neuronal information in different spatial-temporal dimensions
to achieve higher level brain integration. Indeed, neuron-astrocyte communication at synapses regulates
breathing, memory formation, motor function, and sleep, and are implicated in many neuropsychiatric disorders.
All these results provide strong rationale for studying astrocyte function, which will provide unprecedented
insights to our understanding how astrocytes function to regulate and protect brain and how these functions can
be exploited for astrocyte-based therapeutic targets.
Although there is a moderate understanding of functional significance of astrocytes, a mechanistic and
comprehensive understanding of the active functional roles of astrocytes in neural circuitry and behaviors is
largely lacking. One major challenge in deciphering the functional roles of astrocyte is its complex signaling
patterns resided in both spatial and temporal domains. Funded by last award, we have developed an event-
decomposition framework and the method AQuA (Astrocyte Quantification and Analysis) to model the complex
astrocyte signaling. AQuA was considered as a paradigm shift and turning point for astrocyte analysis by multiple
review papers and is now widely used by many labs in the world.
With the technical advances largely enabled by BRAIN Initiative, large-scale, multiplex imaging and manipulation
of multiple circuit components in astrocyte-neuron network are now feasible. The increased complexity and
amount of imaging dataset demand further development of powerful computational tools beyond AQuA. The
large volume whole-brain activity data and the new imaging capability of signals beyond Ca2+ require significant
improvements in speed, scalability, accuracy, and flexibility. The simultaneous recording of multiple intra/extra-
cellular signals calls for new modeling framework and computational methods. Thus, building on our previous
success, the overarching goal of this renewal project is to further develop novel computational methods and
analytical tools to decode the functional roles of astrocytes in neural circuits and behavior.
We will team up with experimental biologists to prototype, validate and integrate our computational tools with
wet-lab experiments across species and biological questions. We expect a team science of close collaborations
between computational and experimental scientists will enable new discoveries. Ultimately, a successful
outcome will significantly enhance our mechanistic and theoretical understanding of astrocyte function in neural
circuitry and behaviors. These understandings will be essential to development of new therapeutic drugs and
strategies, which haven’t been changed in the past 30 years for neurological and neuropsychiatric disorders.

Public health relevance
Project Narrative Although astrocytes, the most abundant glia cells in the brain, have been proposed to play important roles in the neural circuitry and behaviors, a mechanistic and comprehensive understanding of the active functional roles of astrocytes in neural circuitry and behaviors is largely lacking partially due to the difficulty in modeling the complex astrocyte activity data. We thus propose to apply advanced machine learning and data science theory to develop advanced computational methods and analytical tools. A deep understanding of bi-directional astrocyte-neuron signaling in health and disease could lead to novel therapies for brain disorders.